Research Computer Programming Module

The Research Computer Programing Module of the Center Core Grant for Vision Research
provides software design and development services to support and advance innovative research
at the University of Houston. The Module provides project management of custom research
software and develops or supervises development of software when the scope or sophistication
of the project goes beyond what an individual investigator’s lab can undertake. The principal
developer interacts closely with investigators to clarify and document the software requirements,
taking into consideration their unique needs regarding the user experience and data
management, as well as technical requirements of the application. The Module also provides
consultation with investigators who develop their own software, including Core investigators, their
collaborators, newly hired investigators, research staff and graduate students. The scope of this
assistance includes guidance on available campus resources, implementing algorithms, source-
code control, data management, and communication with vendors on technical issues. The
Module maintains code and documentation in repositories as research staff rotate through labs,
providing for continuity. The Research Computer Programming Module is supervised by Vallabh
Das, PhD, Moores Professor of Optometry and Vision Science, with a joint appointment in
Biomedical Engineering. Dr. Das is an NEI-funded investigator (18 yrs) who has extensive
expertise in software development for neurophysiological investigations of the oculomotor
system.